Advancing Standardization of Neurophysiology Data Through Dissemination of NWB

PROJECT SUMMARY
Lack of standards for neurophysiology data and related metadata is the single greatest impediment to fully
extracting return on investment from neurophysiology experiments. One of the greatest questions in science
today is understanding how the brain works and gives rise to thoughts, memories, perception, and
consciousness. To address this challenge, neurophysiologists within the NIH BRAIN initiative and around the
world perform experiments that measure neuronal activity from different parts of the brain and relate that
activity to sensation and behavior. A key component of the BRAIN Initiative is to support sharing of these rich
datasets and extend their value by enabling reuse of data within and across labs. The goal of this proposal is
to disseminate Neurodata Without Borders (NWB) neurophysiology technologies developed as part of the NIH
BRAIN Initiative broadly to the neuroscience research community. NWB is an award-winning,
community-driven data standard and software ecosystem for neurophysiology. To facilitate data sharing and
reuse, the NWB format standardizes how neurophysiology data and associated metadata are stored, and the
NWB software enables researchers to access and save data in the NWB format easily and efficiently. Several
leading neuroscience labs and institutions now produce data in NWB; however, a substantial energy barrier
remains for labs to standardize their data. To lower the barrier of adopting NWB, we propose a multifaceted
plan to make NWB easier to use by focusing on the needs of 1) neuroscience researchers and laboratories by
enhancing user training, support, and coverage of new technologies and 2) neuroscience tools and
technologies by maintaining core NWB technologies and integrating with a wide array of powerful data tools
and technologies. With NWB data as a target, scientists can access, manage, and share data using common
protocols, while developers have a common format on top of which to build tools. By targeting these two areas
simultaneously, we aim to reduce cost, time, and effort for analysis; improve quality, reliability, and accuracy of
results; and enable scientists to access new scientific capabilities. Successful completion of the proposed work
will enable broad dissemination of NWB to neuroscience labs and researchers and integration of NWB with
neuroscience tools, providing the research community with an accessible data standard and software
ecosystem that enhances utilization, sharing, quality, reliability, and analysis of neurophysiology data.

Public health relevance
PROJECT NARRATIVE Lack of standards for neurophysiology data and related metadata is the single greatest impediment to fully extracting return on investment from neurophysiology experiments. The goal of this proposal is to disseminate the award-winning, community-driven Neurodata Without Borders (NWB) neurophysiology data standard and software technologies developed as part of the NIH BRAIN Initiative broadly to the neuroscience research community. To lower the barrier of adopting NWB, we propose a multifaceted plan to make NWB easier to use by focusing on the needs of 1) neuroscience researchers and laboratories by enhancing user training, support, and coverage of new technologies and 2) neuroscience tools and technologies by maintaining core NWB technologies and integrating with a wide array of powerful data tools and technologies.